The role of beta agonists in the treatment of chronic kidney disease

Diseases affecting podocytes and the glomerulus, such as diabetes, are the leading cause of end stage kidney
disease (ESKD). Eleven percent of Veterans meet the established criteria for chronic kidney disease (CKD),
which leads to ESKD and premature death from cardiovascular disease. The vast majority of research in the
field of CKD has focused on the initiating events and causes of CKD; unfortunately, this approach does not
represent what is seen clinically where CKD is identified after the injury occurs. Because therapeutic options
for recovery from CKD are either severely limited or non-existent, there is a critical need for novel targets and
therapeutics. The goal here is to validate a novel therapeutic target, the beta 2 adrenergic receptor (β2-AR),
that we recently showed accelerates recovery of glomerular function following injury. Glomerular function is
highly dependent on specialized cells known as podocytes, which are critical components of glomeruli. While
podocyte injury is a common denominator in many glomerular diseases, there are no specific drugs that restore
injury-induced loss of podocyte structure and function. Bioinformatics analysis following injury revealed
induction of genes related to mitochondrial function. Mutations in mitochondrial genes are known to result in
mitochondrial dysfunction and have been implicated in the loss of podocyte function. Since mitochondria are
known to play a critical role in maintaining podocyte energy homeostasis, we hypothesized that podocytes
could recover from injury by increasing mitochondrial biogenesis, and therapeutics that increase mitochondrial
biogenesis would promote recovery from glomerular injury. To test this hypothesis, we investigated whether
stimulation of the β2-AR by an agonist would induce mitochondrial biogenesis and restore glomerular filtration
function in injured mice. Our recently published studies and preliminary data show a potent induction of
mitochondrial biogenesis in podocytes by the long-acting β2-AR agonist formoterol. Importantly, using mouse
models of podocyte injury, we demonstrated that oral and intraperitoneal administration of formoterol six hours
following injury, when glomerular dysfunction is already established, restored glomerular structures,
significantly reduced proteinuria, and accelerated recovery of glomerular function. We also show preliminary
data indicating that Veterans with CKD and chronic obstructive pulmonary disease (COPD), who use β2-AR
agonists, have a significantly slower decline of renal function. Since diabetes is the leading cause of CKD and
ESKD, these clinical findings are most likely due to the effect of β2-AR agonists on diabetic nephropathy.
Indeed, we have new data showing that formoterol use results in recovery from diabetic nephropathy in a
mouse model of type II diabetes. Thus, we further hypothesize that treatment with formoterol accelerates
the recovery of glomerular function following injury through the induction of podocyte mitochondrial
biogenesis. To test this, we will investigate β2-AR-dependent mechanisms that participate in podocyte
recovery by utilizing β2-AR knockout mice (β2-ARfl/fl;podocin-CreTg/+) and β2-AR-deficient podocytes derived
from these mice. This will allow us to determine the mechanism of action of formoterol and possibly identify
even more efficacious treatments (Aim 1). We will then assess the clinical value of using formoterol to
molecularly target β2-AR-induced mitochondrial biogenesis to prevent or slow podocytopathy and CKD in a
wide range of glomerular diseases, including Alport syndrome, loss of the podocyte slit diaphragm protein
CD2AP, lupus nephritis, and diabetic nephropathy, the single most common cause of CKD and ESKD (Aim
2). Finally, we will perform a large retrospective cohort study to further evaluate the association between long-
term β2-AR agonist use and decreased loss of renal function that we have identified in Veterans (Aim 3).
Successful completion of this proposal, using a multifaceted approach that includes cell culture, animal
experiments and human studies, will provide justification for a prospective randomized clinical trial to establish
β2-AR agonists, which are both safe and inexpensive, as an efficacious treatment for CKD.

Public health relevance
Diseases affecting the filters of the kidney (podocytes and glomeruli), such as diabetes, are the leading cause of end stage kidney disease (ESKD). Eleven percent of Veterans meet the criteria for chronic kidney disease (CKD), which leads to ESKD and premature death from cardiovascular disease. As a kidney doctor at the VA and in the South Carolina Army National Guard, I frequently see patients with CKD, and it is difficult to tell them there are very few specific therapies to treat CKD. A safe, approved, and efficacious drug would be a major advance. The goal here is to validate a novel therapeutic target, the beta 2 adrenergic receptor (β2-AR), activation of which we showed accelerates recovery of kidney function following injury, including in a diabetic mouse model. Formoterol, which activates the β2-AR, is an approved drug with an excellent safety profile used to treat chronic obstructive pulmonary disease (COPD). This application investigates, using mouse models and a retrospective cohort study of Veterans, the utility of repurposing β2-AR activators such as formoterol for the treatment of CKD.